The role of sex chromosomes in neonatal hyperoxic lung injury

PROJECT SUMMARY
Bronchopulmonary dysplasia (BPD) is the most common complication affecting preterm neonates and is
defined by supplemental oxygen dependence at 36 weeks postmenstrual age. Advances in neonatal care have
improved overall survival of preterm neonates though BPD prevalence continues to increase. BPD develops
after early-life lung injury caused by myriad pre- and postnatal factors such as the administration of
supplemental oxygen. Though a lifesaving therapeutic intervention, high concentrations of oxygen (hyperoxia)
arrest alveolarization and vascularization and induce inflammation. Neonates with BPD face challenges in lung
function that can persist throughout adulthood. BPD has a striking male bias for both incidence and severity,
demonstrating the need to interrogate sex as a biological variable in lung development, injury, and repair
processes. Previous work from our lab showed that female chromosome complement (XX) is protective
against lung injury, independent of gonadal sex (ovaries and testes). It is unknown if the protective effect is due
to the presence of two X chromosomes or the absence of a Y chromosome. The goal of this proposal is to
interrogate dosage sensitivity of sex chromosomes and an X-linked gene, Kdm6a, in an early-life hyperoxia
mouse model of BPD. I hypothesize X chromosome mechanisms and dosage contribute to female resilience
against hyperoxic lung injury. This hypothesis will be tested by the following: Aim 1) Determine the role of sex
chromosome dosage in neonatal hyperoxic lung injury and Aim 2) Determine the role of endothelial Kdm6a in
neonatal hyperoxic lung injury. In Aim 1, I will assess lung morphometry and vascularization in room air and
hyperoxia-exposed in the XY star (XY*) mouse model that has XX, XO, XY, and XXY genotypes. My
preliminary data shows modulation of alveolarization after injury as a function of chromosome dosage. I will
then determine cell-type specific gene signatures after hyperoxia exposure using single-cell RNA sequencing.
In Aim 2, I will determine the role of endothelial Kdm6a in female neonatal mouse pups during development
and after hyperoxic lung injury. X chromosome inactivation (XCI) is a dosage compensation mechanism
whereby supernumerary X chromosomes are transcriptionally silenced so genes from only one X chromosome
are expressed. However, some genes escape XCI. Intriguingly, preliminary data from our lab show a female-
specific induction of an XCI escapee, Kdm6a, after exposure to hyperoxia. I will test the hypothesis that
endothelial knockdown of Kdm6a intensifies hyperoxic lung injury in female mice. To determine the role of
Kdm6a in epigenetic regulation and alterations to the chromatin landscape, I will perform bulk RNA-seq, ATAC-
seq, and CUT&RUN. Completion of this proposal will advance mechanistic knowledge of sex-specific
responses to respiratory insults and potentially inform the development of precision medicine approaches.

Public health relevance
PROJECT NARRATIVE Bronchopulmonary dysplasia is a chronic lung disease that primarily affects male preterm neonates and is the most common complication associated with preterm birth. Sex chromosomes can contribute to sex-biased disease outcomes through expression of genes found on chromosomes X and Y. We will determine the role of sex chromosome dosage and the role of an X-linked gene, Kdm6a, in driving sex-specific outcomes in a mouse model of bronchopulmonary dysplasia to provide insight into new mechanisms and therapeutic targets that may be protective against disease.